Applied Research Component: Improving genetic resources available to the research community

Project Summary
The Bloomington Drosophila Stock Center (BDSC) supports a large, worldwide community of scientists using
the insect Drosophila melanogaster as a model organism for biomedical experimentation. The goals of the
BDSC are to provide a collection of documented living stocks of broad value to current research, to preserve
documented strains with clear future value, and to provide information and support services that promote
maximal exploitation of these materials. These goals facilitate research by providing universal and rapid
access to the most generally useful stocks, by preserving specialty genotypes with exceptional characteristics,
and by providing information that helps researchers identify stocks appropriate to their needs. Drosophila is
used extensively in studies of biological processes relevant to human health and investigations of molecular
mechanisms underlying disease, because genetic technologies available to Drosophila researchers are among
the most sophisticated in any multicellular organism. As the most comprehensive source of stocks for genetic
experimentation with Drosophila, the BDSC is central to the success of many research projects including a
large number of NIH grants. The first specific aim of this proposal is to continue acquiring, maintaining and
distributing Drosophila strains and to continue developing associated information resources to meet the
research needs of Drosophila scientists while maintaining and promoting excellent user support. Key to this
aim is the administration and advancement of the highly successful cost recovery program that finances
operational expenses from user fees. Consequently, the proposal focuses on support and development of the
core management team as the most effective way to leverage the investment of NIH resources. The second
specific aim, which will comprise 10% of grant expenditures, is to undertake research to increase the utility of
the two largest subsets of BDSC stocks. Stocks carrying GAL4 or split-GAL4 transgenes are used to force
expression of other transgenes in cell-specific patterns, allowing investigators to manipulate cell characteristics
experimentally in otherwise normal individuals. They form the bases of many experimental approaches in
Drosophila and most Drosophila models of human disease mechanisms, and the research here aims to
characterize their expression patterns in the intestine, the most useful model system for studying the cell
proliferation dynamics of a self-renewing epithelial tissue. Stocks carrying transgenes capable of expressing
double-stranded RNAs under the control of GAL4 or split-GAL4 transgenes are used to knock down
expression of specific genes via RNA interference mechanisms. A large collection of these stocks has been
generated and preliminarily characterized. The research proposed here, in collaboration with the Transgenic
RNAi Project at Harvard University, will evaluate the efficacy of these stocks in greater depth.

Public health relevance
Project Narrative The Bloomington Drosophila Stock Center is the U.S. repository and distribution center for genetically characterized strains of Drosophila melanogaster, an insect used in thousands of laboratories worldwide both to investigate fundamental biological processes and to understand cellular mechanisms related to human diseases.